Macrocyclic Arenes as Sequestrants for Drugs of Abuse

PROJECT SUMMARY. Over 1.25 million emergency department visits occur annually due to the abuse of illicit
drugs and prescription opioids resulting in an estimated cost to the United States of $37 billion/year in healthcare
costs and $271.5 billion/year overall when crime and lost productivity are included. The majority of these cases
were due to cocaine (40%), heroin (21%), (meth)amphetamines (13%), and PCP (6%) with numbers rising in
recent years for fentanyl, fentanyl analogues, and drugs (e.g. cocaine) laced with fentanyl. For this reason, the
federal government considers the drug abuse (opioid) epidemic to be a national emergency. Currently, opioid
overdose can be treated with Naloxone which binds to / blocks the opioid receptor in the brain. However, with
the rising abuse of fentanyl, Naloxone is becoming much less effective and multiple doses are often required.
Furthermore, there are no current specific antidotes for intoxication with stimulants (e.g. methamphetamine,
cocaine, or mephedrone) or for hallucinogens (e.g. ketamine or PCP) and ER doctors deliver treatments that
only target the patient’s symptoms. Accordingly, the development of new antidotes that treat intoxication with
the full range of drugs of abuse (opioids, stimulants, hallucinogens) is urgently needed. In contrast to small
molecule strategies that antagonize the opioid receptor, the molecular container strategy sequesters the drug
itself in the bloodstream of the animal and promotes its clearance. Macrocyclic arenes are molecular container
compounds that can possess tight binding (Ka ≥ 107 M-1; Kd ≤ 100 nM) toward hydrophobic cations in PBS which
renders them a prime platform to create new in vivo sequestration agents for drugs of abuse. We propose to
systematically vary the structure of the macrocyclic arene hosts to optimize the binding affinity toward specific
drugs of abuse. For example, we will optimize the location of the anionic groups to maximize ion-ion electrostatic
interactions and deepen / widen the macrocyclic arene cavity to enhance the hydrophobic driving force toward
host•drug complexation. New sequestration agents will be subjected to a series of in vitro toxicology and in vivo
maximum tolerated dose studies to establish their biocompatibility. Finally, hyperlocomotion assays will be used
to determine the in vivo efficacy of the most promising sequestration agent / drug pairs. Upon completion of the
proposed project we expect at least one sequestration agent will be nominated to continue toward US FDA
investigational new drug status.

Public health relevance
Project Narrative: Drug abuse and overdose results in hundreds of thousands of emergency room visits, hospital admissions, and deaths which imposes a large financial cost on the Unites States healthcare system. Guided by molecular modelling, we will synthesize novel water soluble and high affinity macrocyclic arene (prismarenes and pagodaarenes) and measure their binding affinity toward a panel of drugs of abuse (DOA) followed by in vitro and in vivo toxicology and finally in vivo efficacy studies to identify a lead in vivo supramolecular antidote for intoxication with DOAs. The project promises to impact human health by reducing the mortality and health care costs associated with DOA intoxication.